Biostatistics & Clinical Research Core

Pediatric HIV/AIDS & Infection-Related Malignancies Research Consortium for Sub-Saharan Africa
(PARCA): Biostatistics & Clinical Research Core (Core C)
The responsibilities of the Biostatistics & Clinical Research Core (Core C) include support of the individual
projects and other cores, as well as the overall data management for the Consortium as a whole.
To accomplish these objectives, the Aims of the Biostatistics & Clinical Research Core are:
1. Data Management: To maintain relevant databases, administer data quality assurance, data security
and backups, provide and facilitate information retrievals and reports, monitor the progress of all
studies, update hardware and software, provide and improve documentation.
2. Design of Studies and Experiments: To work with all projects and cores to develop appropriate study
designs, analytic plans, and sample size estimations and determine feasibility for the pilot projects.
3. Statistical Analyses: To analyze data produced by the Projects and Cores in accordance with the
analytic plans generated in Aim 2.
4. Quality Assurance and Regulatory Compliance: To conduct analyses to ensure the quality of the
data collected or generated by laboratory and pathological analyses of biospecimens; to ensure that
research is conducted according to international ethical and regulatory standards.
These services will be provided across all three Projects and will support the activities in the other Cores. The
Biostatistics & Clinical Research Core will be co-led by Dr. Ssenkusu (Biostastician and Lecturer, Makerere
University College of Health Sciences – School of Public Health (MakCHS–SPH) and Dr. Hilsenbeck
(Biostastician, Professor, Baylor College of Medicine (BCM), and Director of the Quantitative Sciences Shared
Resource in the BCM Dan L. Duncan Comprehensive Cancer Center).

Public health relevance
Pediatric HIV/AIDS & Infection-Related Malignancies Research Consortium for Sub-Saharan Africa (PARCA): Biostatistics & Clinical Research Core (Core C) The responsibilities of the Biostatistics & Clinical Research Core (Core C) include support of the individual projects and other cores, as well as the overall data management for the Consortium as a whole. To accomplish these objectives, Biostatistics & Clinical Research Core will oversee data management, study design, statistical analyses, and quality assurance and regulatory compliance for PARCA research projects.